The role of G3BP granules in mRNA translation regulation and cell adaptation to exogenous stress

Project Summary/Abstract
G3BP stress granules (SGs) are a component of the eukaryotic stress response. They are membrane-less
organelles that form as a consequence of eIF2⍺ phosphorylation and global translation inhibition. The role of
G3BP granules during cellular stress is not completely understood. They are composed of untranslated mRNAs
and factors from the translational machinery leading to the model that G3BP SGs inhibit translation through the
sequestration of macromolecules from the bulk cytoplasm. Furthermore, the biological function of G3BP granules
may be regulated by their liquid-like properties. This feature may allow G3BP SGs to interact dynamically with
the bulk cytoplasm and to reversibly dissociate when cells recover from stress. Moreover, it has been proposed
that SG transitioning to solid-like structure during prolonged stress is detrimental to survival. However, detailed
characterization of G3BP granules liquid stability and their role in cell survival during stress response is still
lacking. I hypothesize that G3BP granules protect mammalian cells against stress by regulating translation of
mRNAs and retaining a stable liquid-like phase in the bulk cytoplasm. To test the direct role of G3BP granules
in translation inhibition, in my aim 1, I will characterize the protein and RNA composition of G3BP granules under
exogenous stress in human cells through APEX2-proximity labeling coupled to RNA sequencing and Mass
Spectrometry. Furthermore, to decouple the effects that stress induction may have on SG composition, I will
characterize the protein/RNA molecules associated to SGs induced with optogenetics. Then, I will perform the
Transcript Isoforms in Polysomes sequencing (TrIP-seq) technique, which characterizes the abundance of
mRNAs associated to polysomes, to define the relationship between SG recruitment of mRNAs and their
translation. To test the biological function of G3BP SG biophysical properties to cell survival, in my aim 2, I will
study the liquid stability and reversibility of G3BP granule formation under acute and chronic stress with a
microfluidics-based fluorescence microscopy approach currently developed in the Floor and Wittmann
laboratories at UCSF. Then, I will evaluate transitions in the material properties of G3BP granules by performing
fluorescence recovery after photobleaching (FRAP) experiments. Finally, I will determine the viability of cells
through a propidium iodide-based assay to elucidate the role of liquid stability and kinetics of granule formation
to survival from stress. In summary, this project will provide insights into the physiological role of G3BP granules
to survival during the stress response and recovery and the biological function of their liquid stability in promoting
cellular adaptability under exogenous stress.

Public health relevance
Project Narrative G3BP stress granules are membrane-less organelles that form in the cytoplasm of eukaryotic cells during the stress response. Their role in cellular adaptation and recovery from stress is not completely understood, and dysregulation of these structures is linked to the progression of diseases like amyotrophic lateral sclerosis and cancer. Understanding the biological function of G3BP granules and their dynamics will provide insights into their role to cell survival during the stress response in physiology and may provide new avenues to design therapeutic approaches against SG-driven pathologies.